Biostatistics, Bioinformatics, and Research Informatics Shared Resource

ABSTRACT: BIOSTATISTICS, BIOINFORMATICS, & RESEARCH INFORMATICS SR (BBRISR)
The Biostatistics, Bioinformatics, & Research Informatics Shared Resource (BBRISR) plays a major role in
collaborative efforts and project leadership across the Sidney Kimmel Cancer Center (SKCC) and provides
SKCC investigators and other Shared Resources (SR) with centralized access to high-quality, state-of-the-art
data collection, management, and analytic services through a coordinated, multi-faceted data science team. The
SR was founded as the Biostatistics Shared Resource (BSR) in 1994 and has been continuously funded by the
CCSG since 2001. In 2022, the BSR was expanded to incorporate capabilities in Bioinformatics (previously
located in the MetaOmics SR) and Research Informatics (previously located in the Translational Pathology SR)
to avoid duplication of efforts, enhance collaboration among computational staff, and provide a centralized
resource for all data management and analytic needs. The BBRISR provides guidance on study design,
database building and integration of diverse data types, development of statistical and bioinformatics analyses
for grant applications and clinical/translational protocols, data analysis, and preparation of reports and
manuscripts. The BBRISR supports investigators in all basic, translational, clinical, and population research
activities and plays a critical role in SKCC community outreach and engagement, education, and training.
The BBRISR is led by Co-Directors Benjamin Leiby, PhD and Christopher McNair, PhD. Leiby is Director of the
Division of Biostatistics in the Department of Pharmacology, Physiology, and Cancer Biology. He previously
served as Director of the BSR. McNair is Associate Director for Data Science for SKCC. As a large, newly
expanded SR, complementary expertise of the Co-Directors allows optimal oversight of all components of
BBRISR. The BBRISR is located in office suites in the Edison Building and 833 Chestnut, readily accessible to
all SKCC members via a short walk (<1 mile). The Specific Aims of the BBRISR are to: 1) Support cancer
research data analytics, 2) Manage cancer research informatics and data, and 3) Provide education and training
to SKCC members, staff, and trainees. During the project period, the BBRISR served 129 SKCC members, 66
(51.2%) of which had peer-reviewed funding, representing all four Research Programs. BBRISR services were
utilized by 154 total users in 199 peer reviewed publications (average impact factor 8.36), 250 grant applications
(41 funded, 43 pending), and 82 clinical trials.
In line with the SKCC strategic plan, IMPACT PHL, the BBRISR has set goals for targeted recruitment in four
areas: 1) Faculty and staff in Bioinformatics, 2) Faculty with expertise in Informatics and analysis of Electronic
Medical Record (EMR) data, 3) Biostatistics faculty with expertise in causal inference for observational data, and
4) Staff project manager to assist the Co-Directors with day-to-day operations and ensure timely delivery of
services.